Aberrant Splicing in the Cardiac Arrhythmias

PROJECT SUMMARY/ABSTRACT
The increasing use of whole genome sequencing (WGS) is uncovering large numbers of rare non-synonymous
variants in recognized disease genes in both healthy and diseased individuals. Most of these are currently
classified as Variants of Uncertain Significance (VUS’s) and understanding the functional effects of these
variants is a required next step for the implementation of genomic medicine. WGS is also uncovering variation
leading to aberrant splicing, an increasingly well-recognized disease mechanism. Current estimates suggest that
10% of all pathogenic variants in Mendelian diseases arise from abnormal splicing. The study of Mendelian
cardiac arrhythmia disorders has not only illuminated normal and abnormal cardiac electrophysiologic
mechanisms, but has propelled increasingly routine clinical genetic testing for patients thought to be at risk for
outcomes such as sudden cardiac death – which kills >250,000 Americans each year – and Early-onset Atrial
Fibrillation (EoAF). Key genetic arrhythmia diseases predisposing to SCD include the long QT syndromes
(LQTS) and Brugada Syndrome (BrS), while work at Vanderbilt and elsewhere has implicated a range of
channelopathy and cardiomyopathy syndromes in EoAF. The absence of a focused effort to identify variants that
contribute to aberrant splicing among these diseases constitutes a barrier to clinical actionability. This work will
address our incomplete knowledge of splice-perturbing variants in the arrhythmias. I hypothesize that genetic
variation affecting splicing contributes to the genetic arrhythmias. I will therefore deploy a series of functional
investigations using recent advances in human genetics and molecular biology to assess aberrant splicing. First,
I will use minigene and CRISPR-Cas9 assays to assess the impact of putative splice-altering VUS’s in BrS and
LQTS. Variant reclassification is essential for improving the yield of genetic testing in these diseases. Second,
I will adopt a high throughput minigene assay to determine the impact of genetic variation on SCN5A alternative
splicing and design antisense oligonucleotides to modulate this splicing. This represents a potential therapeutic
approach for patients affected by rare variants in a developmentally alternatively spliced exon. Third, splice-
altering variation will be investigated in arrhythmia and cardiomyopathy genes in a large cohort of EoAF patients
who have undergone WGS. Variants introducing cryptic splice sites will be targeted by antisense
oligonucleotides and small molecules to reverse the phenotypic effects of variants in a disease-relevant model.
Collectively, these studies will significantly advance our understanding of splicing as a contributory mechanism
among the genetic arrhythmias. This project, complemented by rigorous coursework in human genetics and
clinical training in inherited arrhythmias, will provide substantial opportunities to develop techniques and
proficiency in translational genetics to support my goal of becoming a leading physician scientist.

Public health relevance
PROJECT NARRATIVE The cardiac arrhythmias are a diverse set of pathologies with genetic underpinnings and clinical consequences ranging from benign palpitations to sudden cardiac death, a condition which claims >250,000 lives a year. An overlooked disease etiology is genetic variation inducing aberrant splicing, a mechanism not yet thoroughly explored in the arrhythmias. The purpose of my research is to improve our understanding of genetic variation perturbing splicing for diagnostic value in precision medicine, and to extend these insights by exploring therapeutic approaches in pre-clinical models.